Making Biomedical Data Resources and Visualizations Accessible

There is a notable discrepancy in the population of individuals with disabilities between the scientific workforce and US adults, implying potential barriers for individuals with disabilities to join the workforce. While making data and visualization resources accessible and useful is vital in genomics education, research, and clinical settings, genomics resources such as data portals, visualizations, and research papers largely fail to meet accessibility standards according to our preliminary evaluation (96.3% of 2,936 evaluated portals), making essential resources rather inaccessible to people with visual impairments. My overarching goal is to help people with disabilities in the genomics workforce by enhancing the accessibility of data and visualization resources. This project proposes three specific aims: (1) conducting accessibility evaluations of biomedical resources, (2) developing accessible visual and textual representations for genomics data and novel tools based on them, and (3) implementing accessible graphical user interfaces for genomics data analysis. I will conduct a series of comprehensive accessibility evaluations of biomedical resources with input from users. Based on the evaluation results, I will build accessibility guidelines for biomedical resources and their priorities based on different use cases, which will complement general accessibility guidelines. The evaluations will unveil critical aspects of potential improvements and offer guidance toward accessible biomedical resources. Second, by extending my earlier work on the Gosling grammar-based genomics data visualization, I will help content creators to build accessible genomics data tables and visualizations, which will offer smart accessibility defaults and out-of-the-box accessibility features. Based on the extended Gosling, I will develop an assistive toolkit that will automatically generate missing metadata and refine the structure of web pages to enable viewing currently inaccessible data tables and figures in existing web-based genomics resources. Given the complexity and scale of genomics data, user interactions, such as zooming and panning, are essential techniques for genomics data analysis. However, traditional mouse-based interactions are largely inaccessible without accurate vision. As the last aim, I propose to design accessible and intuitive user interactions tailored for genomics visualization, such as keyboard-based interactions. Building on top of the accessible interactions, I will build an accessibility-friendly graphical user interface (GUI) platform that enables people with visual impairments to create visualizations and analyze genomics data. The novel tools I will develop will not only help content creators to efficiently and accurately create accessible visualizations but also enable current and prospective genomics students, researchers, and clinicians with visual impairments to access, interpret, and analyze genomics data, making data-driven genomics research more accessible.

Public health relevance
There is a notable discrepancy in the population of individuals with disabilities between the scientific workforce and US adults, implying potential barriers for individuals with disabilities to join the workforce. I will identify barriers to accessing genomics data resources and visualizations through comprehensive evaluations and implement novel tools by designing accessible representations, interactions, and interfaces that will complement screen reader and magnifier assistive technologies. The developed tools will not only help content creators to efficiently and accurately create accessible data resources and visualizations but also enable current and prospective genomics students, researchers, and clinicians with visual impairments to access, interpret, and analyze genomics data.